The Effect of Smart Ambient Bright Light for Nursing Home Residents with Alzheimer's Disease and Related Dementias

Abstract
Up to 90% of people with Alzheimer’s disease and related dementias (ADRD) experience at least one behavioral
and psychological symptom of dementia (BPSD). Agitation is among the most common and challenging BPSD,
especially in nursing home (NH) residents with ADRD. Thus, identifying an effective, non-pharmacological
intervention to reduce agitation and other BPSDs is critical. Lighting is important for people with ADRD, especially
those living in NHs, as they are not exposed to sufficient daylight. Lighting interventions (LIs) work to regulate
suprachiasmatic nuclei, maintain stable circadian rhythm and reduce agitation. LIs are not invasive and have
minimal adverse effects, making them ideal interventions for persons with ADRD. Evidence has reported that
LIs show improvement in agitation and other BPSDs for persons with ADRD. However, LIs have not been widely
implemented in “real world” care settings. Traditional methods using light boxes that required persons with ADRD
to sit and keep their eyes oriented toward a bright light led to compliance and workload issues. A more efficient
approach to deliver LIs is necessary. Interest has arisen in designing NHs with the capability of providing LIs via
ambient LIs. While a few studies have reported positive effects of ambient LIs on agitation, these studies were
conducted in settings with window shades closed to minimize daylight. To establish ambient lighting as a feasible
and effective intervention, a few fundamental gaps need to be addressed: 1) a feasible implementation approach
to ambient LIs, and 2) intervention fidelity (ensuring the lighting received by participants meets the targets). This
proposed study seeks to develop a smart ambient bright light (SABL) intervention to provide auto-controlled,
consistent indoor lighting that incorporates natural daylight. This SABL includes tunable LED lights,
photosensors, and controllers. The SABL system has a pre-programmed 24-hour control schedule for
illuminance settings to mimic the natural bright-dark cycle and will automatically adjust the lights to accommodate
the daylight effect to minimize staff burden and maximize the LI effect. The SABL will be installed in participants’
bedrooms and designated areas in the dining rooms and activity rooms for 4 weeks. Each pparticipant will wear
a personal light monitor to measure the lighting dosage each participant receives. This study will address three
aims: 1) pilot test the effect of SABL on reducing agitation in persons with ADRD, 2) evaluate the fidelity of the
SABL delivery, and 3) evaluate the feasibility of implementing the SABL. The study will be conducted in two NHs
in Pennsylvania. For aims 1 and 2, we will use a crossover, cluster randomized control trial (RCT) and will enroll
40 residents with ADRD and agitation. For aim 3, we will use a mixed methods design and will interview 16 NH
staff/administrators to evaluate the acceptability, feasibility, and appropriateness of the intervention. This is the
first study that incorporates daylight in ambient light interventions and the first study that addresses the
measurement, feasibility, and fidelity of lighting interventions. Findings will establish evidence-based
implementation strategies and best design for SABL to reduce agitation for persons with ADRD in NHs.

Public health relevance
Project Narrative Agitation occurs in 93% of persons with Alzheimer’s disease and related dementias (ADRD) living in nursing homes and is a challenging behavioral symptom for persons with ADRD and their caregivers. Lighting interventions have shown a positive impact on agitation; yet the design, measures, and clinical feasibility of implementing these interventions have not been well established. This study will develop a smart ambient bright light (SABL) intervention incorporated with daylighting to automatically provide a 24-hour lighting scheme and will evaluate its effects, along with intervention fidelity and feasibility, which will inform the design of ambient lighting interventions to reduce agitation for persons with ADRD living in nursing homes.